Dialysate regeneration based on photo-electrochemical urea oxidation and reactive adsorption systems

Project Summary/Abstract
In Phase I of this program (STTR), we demonstrated that we could engineer our patented dialysis system
enabling blood cleansing with just 2 liters of H20 (dialysate solution) to fit into a rollaboard-sized suitcase. This
reduction in form factor is a critical element in commercializing a portable dialysis system to improve patient
outcomes via longer dialysis sessions and also improve patient satisfaction/acceptance, freeing them from
three visits per week to dialysis centers. The portable dialysis system eliminates urea via a TiO2 photo-
activated catalyst that decomposes the urea to CO2 and N2 with 99% efficiency. Our present manufacturing
method for the TiO2 catalyst involves a high temperature, high pressure hydrothermal autoclave. Though it
produces acceptable catalytic activity, reproducibility is poor and due to the extreme conditions in the
autoclave, it will be difficult, maybe impossible, to scale-up and commercialize. We seek funding to develop an
ionized gas plasma-based production system for TiO2 catalyst production. Preliminary trials demonstrate that
we can produce high activity TiO2 catalyst surfaces in reasonable time periods. This SBIR application focused
on the commercialization of our kidney dialysis system, will (1) scale up the plasma production of the TiO2
catalyst, (2) explore chemical doping using carbon, nitrogen, fluorine, phosphorous, silver, gold and platinum,
and (3) demonstrate that our new catalyst surfaces are durable, have good catalytic activity and do not
produce undesirable side-products.

Public health relevance
Project Narrative In this project we are developing improved catalyst production methods for our novel Photo-Oxidation Urea Removal (POUR) technology which will advance the commercialization of our portable AKTIV HD hemodialysis device by enabling scalable and reproducible catalyst production with improved efficiency of urea removal, decreased form factor, and decreased cost. The Kuleana AKTIV HD device will be a suitcase-sized hemodialysis machine that will operate untethered from a water source, allowing the patient to perform their dialysis treatment whenever and wherever they desire, instead of being tethered to large, immobile machines as is done with current hemodialysis treatment. With this new technology, patients can increase their dialysis therapy from 12 hours to over 30 hours per week to more closely match native continuous kidney function and improve patient outcomes that currently have only a 35% five-year survival rate.